Digital monitoring of autonomic activity to detect empathy loss in behavioral variant frontotemporal dementia

PROJECT SUMMARY/ABSTRACT
Patients with behavioral variant frontotemporal dementia (bvFTD) develop progressive and highly distressing
symptoms of social and emotional dysfunction, including loss of empathy for other people. Scientific research
has struggled to understand the specific causes of empathy loss in bvFTD because empathy is difficult to
measure in a way that is meaningful and not biased by other factors, such as caregiver burden, and because
individuals with bvFTD have highly variable patterns of cognitive and behavioral functioning. A relatively
unexplored but promising avenue of scientific inquiry is the role of autonomic nervous system (ANS) activity in
empathy loss in bvFTD. The ANS is comprised of two complementary subsystems, the sympathetic and
parasympathetic nervous systems, which operate together to increase and decrease levels of physiologic
arousal in response to cues from the environment. Patients with bvFTD show subtle abnormalities in ANS
activity that are linked to symptoms of social dysfunction, including loss of empathy, but this line of research
has been hindered by reliance on traditional methods of measuring ANS output, namely hard-wired EKG and
skin conductance sensors, which restrict the movement of the patient and are sensitive to motion artifacts.
Recent advances in wearable smartwatch technology allow for precise, unobtrusive measurement of ANS
activity with built-in motion detectors to account for changes in ANS signals that are due to movement.
Smartwatch technology is well-suited for continuous measurement of ANS functioning to detect subtle
abnormalities that correspond to behavioral measures of empathy in bvFTD. This project has the potential to
identify specific physiologic contributions to empathy loss in bvFTD, which can be used to develop new
treatments and improve early detection of social and emotional dysfunction in bvFTD.

Public health relevance
PROJECT NARRATIVE Loss of empathy is a core symptom of behavioral variant frontotemporal dementia (bvFTD) that negatively impacts daily functioning and is highly distressing to families and caregivers. A relatively unexplored but promising avenue of scientific inquiry is the role of autonomic nervous system (ANS) activity in empathy loss in bvFTD. The overarching goal of this project is to use a smartwatch to identify abnormalities in autonomic activity that are robustly associated with empathy loss in bvFTD and validate digital markers of autonomic abnormalities against behavioral measures of empathy loss and neuroimaging of the salience network.